Enabling the Next Generation of High Performance Pediatric Whole Body MR Imaging

Project Abstract
Motivation: We aim to develop and implement a new approach to transform pediatric MRI. The ultimate goal is
ultra-fast and motion-robust imaging in a dedicated child-friendly environment to enable more children undergo
MRI without anesthesia. For those who still require anesthesia, it will be briefer and lighter, and performed
in a safer environment. This project leverages a small compact magnet, designed for adult brain MRI, with
gradients that enable very fast imaging. With this magnet as an outstanding starting point, we will tailor our
deep experience and multiple successes in developing new MRI approaches to high-density receiver coils, fast
imaging sequences, and new image reconstruction methods to set a new standard for pediatric MRI.
Approach: Although the compact scanner is designed for adult heads, with a 37 cm inner diameter, it can
accommodate children under eight to ten years of age to image any body part. To transform this system for ideal
pediatric scanning, three development aims will be pursued. The ﬁrst is to enable optimal signal reception. This
will be accomplished through creating new receive chain electronics that are matched to the gradient capabilities,
for ultra-high bandwidth imaging. This will be coupled to very thin and formed receive arrays that maximize
the size of the patient that can be accommodated in the small bore of the scanner. The second aim is to
develop methods of obtaining the highest performance out of the system by characterizing and correcting for
its imperfections. This will be coupled to a bespoke approach to peripheral nerve stimulation, enabling maximal
use of the gradients on each patient. These two developments will then be leveraged for high efﬁciency and
motion robust noncartesian scanning. The ﬁnal aim is to develop a full environment and infrastructure that is
well suited to pediatric imaging. Patient preparation and acclimation to MRI will be enhanced by virtual reality.
Support equipment for anesthesia, new physiological sensors, and a novel child-friendly audiovisual system will
be created.
Signiﬁcance: The result of this project will be a revolutionary change in the way that MRI is used and per-
formed for children. MRI will be more available, cheaper, safer, and have markedly improved image quality.

Public health relevance
Project Narrative We will leverage the outstanding magnet and gradients of a unique small bore MRI scanner to create a new standard for unprecedented whole-body pediatric MR imaging. We will develop, integrate, and validate a set of technologies speciﬁcally for pediatric imaging. These include ultra-high bandwidth MRI signal reception from thin form-ﬁtting hardware, high-speed image data acquisition and image reconstruction, and environmental support appropriate for children.